Modeling Pheromone Induced Plasmid and Drug Resistance Transfer

DESCRIPTION (provided by applicant): Project Summary Enterococcus faecalis is a bacterium found in the intestine of humans as well as in a wide variety of ecological niches. While it is not as virulent as Staphylococcus aureus, it resistance to antibiotics and the ease of its spread among its population has long made E. faecalis a serious therapeutic problem. Our proposed research will examine the mechanism employed for the spread of antibiotic resistance in E. faecalis. The antibiotic resistance gene resides in a plasmid. Different plasmids in the same family carry resistance to different antibiotics. However, each cell does not carry every plasmid, as doing so would increase the metabolic load beyond the point of efficiency. Therefore, each type of plasmid must be spread between cells as necessary. The antibiotic resistant plasmid is spread through a direct cell-cell contact process called conjugation, a process in which the donor cells pass the plasmid with the antibiotic resistance gene to recipient cells. The plasmid carried by donor cells encodes the genes for conjugative transfer of the plasmid as well as for a signal peptide. Upon receipt of the plasmid, the recipient cells then become donor cells. The signal peptide produced by the recipient has long been considered a mate sensing molecule for donors to sense the concentration of recipients. Results from our current work using plasmid pCF10 led us to propose that the plasmid encoded signal is a self (or quorum) sensing molecule for donor to sense its own concentration. We hypothesize that through the interplay of the two signaling molecules, the donor and recipient cells alter their conjugative dynamics to maintain their plasmid-present antibiotic resistant subpopulation and plasmid- free, faster growing recipient subpopulation. We further hypothesize that a heterogeneous response to the mate signal by donor cells in a population provides a competitive advantage; to preserve resources, some donor cells respond earlier and at a low concentration of signaling molecules while others respond later and at a higher concentration of signaling molecules. The titration of the cellular response is mediated by two operons in the plasmid. In our current work we have unveiled a noble mechanism which cells employ to respond to the two signaling molecules. In this proposed research we will develop mathematical models to explore the donor-recipient dynamics. A better understanding of the mechanism of plasmid transfer will help us identify a new way to fight conjugative antibiotic resistance transfer.

Public health relevance
Bacterial antibiotic resistance often spreads through conjugative plasmid transfer. The subject of this particular study, Enterococcus faecalis, is a major cause of hospital infection and transmits its antibiotic resistance through conjugation. This work aims to develop better understanding of the pheromone-induced plasmid transfer.